Task 13/C26: Influenza Challenge Models and Assays for Influenza Vaccines

The In Vitro and Animal Models for Emerging Diseases and Biodefense contract provides antimicrobial activity testing capabilities. This contract also provides the development and standardization of small animal and non-human primate models, and may include efficacy testing of vaccines. Vaccines that are efficacious in small animals may be further tested in non-human primate models.